Uncovering Novel Regulatory Pathways and Functions of the Telomerase RNA Component in the Hematopoietic System

PROJECT SUMMARY/ABSTRACT
Mutations in telomerase cause bone marrow failure in patients suffering with dyskeratosis congenita and
other associated telomere biology disorders. While mutations in these patients are found in different components
of telomerase, mutations in genes that regulate the processing of the RNA component of telomerase, TERC, are
the most prevalent. Due to a lack of adequate models and intrinsic difficulties in studying human telomerase in
physiologically relevant cells, the molecular pathways that control TERC biogenesis and decay during
hematopoiesis remain largely unknown. Progress in the field has been hampered by species and even cell-type
specific differences in telomerase biology that limit our understanding of the molecular mechanisms leading to
the disproportionate role of TERC in hematopoietic failure when compared to other components of telomerase.
A better understanding of the molecular regulation of TERC biogenesis and function in hematopoietic cells is
essential for development of novel alternatives for patients, which remain without a cure.
The focus of this proposal is to use different in vitro and in vivo approaches to decipher molecular
pathways controlling TERC biogenesis and decay in blood cells, as well as the function of TERC during erythroid,
myeloid and lymphoid development. We have developed unique models, including targeted hematopoietic
differentiation of human pluripotent stem cells, transplantation of primary CD34+ human stem cells into sub-lethally
irradiated mice, and studies in primary patient samples, that will allow a complete analysis of the
pathways regulating TERC decay and function during hematopoietic development.
For that, two specific aims are proposed that will both identify novel regulators of TERC decay in blood
cells, as well as specific functions of TERC in the hematopoietic system. Aim 1 will determine the role of novel,
recently identified 3'- end RNA deadenylases to TERC processing in the blood, and to which extent different
RNA deadenylases prevent TERC degradation by the exosome. We will complement these experiments with
the identification of the molecular effectors of a novel route for TERC decay, triggered by differential TERC
capping on its 5'- end, and mediated by trafficking to the cytoplasm. We will investigate if modulation of these
different pathways can rescue hematopoietic development in telomerase mutants. Aim 2 will investigate novel
functions of TERC outside telomerase that can explain the disproportionate role that mutations that affect TERC
levels show in bone marrow failure. We have created unique cellular systems where we can uncouple TERC
expression from telomere length, and will utilize them during hematopoietic differentiation to study direct
functions of TERC on DNA damage and regulation of hematopoietic gene expression programs.
These studies will determine the molecular mechanisms controlling TERC decay and function in
hematopoietic cells. Our unique cellular tools, combined with our expertise in telomerase, RNA decay, and stem
cell biology puts us in an ideal position to make a significant impact in this field.

Public health relevance
NARRATIVE Mutations that impact the stability of telomerase RNA molecules are found in most cases of patients suffering from the bone marrow failure syndrome dyskeratosis congenita. In this proposal our goal is to identify novel molecular mechanisms that can be controlled to prevent that mutations found in these patients cause reduced RNA stability, which will rescue hematopoietic development and improve quality of life. We will use a unique combination of molecular and cellular tools that will significantly increase current knowledge on telomerase RNA stability and function in hematopoietic cells that are deficient in patients with bone marrow failure.